Alterations in Ventral Hippocampal CA1 Processing as a Mechanism for Anxiety in Alzheimer’s Disease

PROJECT SUMMARY/ABSTRACT
Anxiety is a highly prevalent and burdensome symptom of Alzheimer disease (AD), especially at early stages,
and is linked to faster decline. Further mechanistic understanding would improve current treatments, which are
suboptimal and/or carry significant side effects. Yet, the pathophysiology of anxiety in AD is unclear. The CA1
region of ventral hippocampus (vCA1), and specifically its deep pyramidal neurons (dPNs), may play a
significant role in anxiogenesis in AD. The vCA1 dPNs are known to increase their activity during anxious
behavior and project to other areas of the broad anxiogenic network, including amygdala, prefrontal cortex, and
hypothalamus. In addition, compared to dorsal CA1, vCA1 features more intrinsic and synaptic excitability at
baseline and appears to be more vulnerable to early AD. Here, our objective is to obtain a cell type-specific
understanding of how AD affects ventral CA1 in order to better understand anxiogenesis in AD. Specifically, we
test the hypothesis that anxiety in AD relates to hyperexcitability of the vCA1 dPNs. This hypothesis is
bolstered by the above, and published and preliminary work suggesting vulnerability of vCA1 in AD-related
anxiety and that, in AD, dPNs are prone to intrinsic hyperexcitability and excitatory-inhibitory imbalance. Using
the 3xTg-AD mouse model, we test our central hypothesis with the following aims. In Aim 1, we use in vitro
electrophysiology and retrograde labeling to elucidate AD-related alterations in synaptic and intrinsic
excitability in vCA1 dPNs defined by their projection area. In Aim 2, we use implantable microendoscope
imaging of GCaMP calcium signals, c-fos immunohistochemistry, and retrograde labeling to determine the in
vivo activity of vCA1 dPNs and projection-defined dPN subpopulations during anxious behavior in AD mice.
This work will provide two major results that will significantly add to the understanding of anxiety in AD, at the
level of circuit architecture and population coding. Our strategy is conceptually and technically innovative by
leveraging cell type-specific circuit knowledge and state-of-the-art approaches to address disease
pathophysiology at a cellular level. In supporting our hypothesis, these experiments will determine which vCA1
dPN subpopulations and what excitability mechanisms would be the focus of future work. More generally,
these results will further a cell type-specific understanding of AD changes in ventral hippocampus, a structure
that has received less attention in mechanistic studies, is highly vulnerable to AD, and is important for not only
anxiety but also social and motivational behaviors.

Public health relevance
PROJECT NARRATIVE This proposal is clinically important by focusing on neural circuits that may be important for eliciting anxiety in Alzheimer disease (AD). By examining biological changes in these circuits at multiple levels, in vitro and in vivo, the results of this work will provide a more sophisticated understanding of disease pathophysiology in this region. This will enable novel strategies to improve anxiety in human AD patients.